NICOTINE WITHDRAWAL ON PSYCHIATRIC SYMPTOMS IN US VETERAN CIGARETTE SMOKERS

The prevalence of smoking is markedly elevated among individuals with schizophrenia; this may be because they are self-medicating with nicotine. We will test the hypothesis that acute nicotine withdrawal exacerbates psychiatric symptoms in US Military Veteran smokers with schizophrenia.